Annual Symposium on Nonhuman Primates

PROJECT SUMMARY
With this R13 application, we request funding to support, in part, the costs for planning, publicizing, and hosting
the 42nd, 43rd, and 44th Annual Symposia on Nonhuman Primate Models for AIDS. For more than four decades,
this symposium has served as the premier scientific forum for the exchange of information, including new
research findings and scientific perspectives, among HIV/AIDS investigators whose research includes studies
in nonhuman primates (NHPs). Disseminating the latest research findings in NHP models of AIDS while also
facilitating discussion and exchange of information between basic scientists and clinicians remains a priority,
as do focusing on emerging technologies to accelerate translation of NHP studies into the clinic and engaging
a broader and more diverse group of researchers in HIV/AIDS research in NHP models. This meeting, the only
one of its kind in the world, convenes an international group of scientists whose research focuses on the study
of natural and experimental immunodeficiency virus infections in NHPs, as well as on the development of novel
therapeutics, prophylactic vaccines for HIV, and curative approaches. Emerging topics in related infectious
diseases (such as COVID-19 pathogenesis, vaccines and treatment) may also be included. The seven
National Primate Research Centers (NPRCs) host this meeting in rotation, and upcoming symposia hosts will
be the Wisconsin (2025), Southwest (2026), and Washington (2027) NPRCs. We plan a hybrid format with
most participants attending in person and others joining online to access oral and poster sessions. The
conference will begin on day 1 with registration, a keynote address by a leading HIV/AIDS researcher, and an
evening reception. The following two and a half days will include scientific presentations from invited speakers
and accepted oral abstracts. Each symposium scientific committee will select session topics and speakers to
highlight new and cutting-edge technologies in their respective fields. Each session will open with a 30-minute
talk by an invited chair. Individuals whose abstracts are accepted for oral presentations will give the remaining
session talks. A poster session will occur on the evening of day 2, and there will be a banquet on the evening
of day 3. As is traditional for this symposium, the Journal of Medical Primatology will publish all poster and oral
abstracts in a special issue. In partnership with the HIV Vaccine Trials Network (HVTN), the NHP AIDS
Symposium will also host a pre-symposium meeting for early-stage investigators (ESI). This meeting will be
open to the attendees of a linked ESI Conference the HVTN sponsors. ESI attendees and mentors will focus
on grant writing, budgeting, and networking, and will participate in a Q&A with NIH Program Officers. We
believe bringing together researchers from a variety of diverse backgrounds will generate future collaborations
and scientific advances. Knowledge shared and gained at upcoming Annual Nonhuman Primate Models for
AIDS Symposia will further the continued, effective use of NHP models to maintain long term control of HIV
replication in the absence of antiretroviral therapy and to design interventions to prevent or eradicate HIV
infection.

Public health relevance
PROJECT NARRATIVE HIV/AIDS continues to be a global concern. With approximately 40 million people currently living with HIV worldwide, it is imperative to develop better treatments and interventions to prevent and/or cure HIV infection. This annual symposium will facilitate and promote the exchange of new research findings, scientific approaches and perspectives, and foster new collaborations among HIV/AIDS investigators whose research includes studies in nonhuman primates (NHPs).